A Point of Care Test for Babesia microti

ABSTRACT
Babesia microti is a parasite that is transmitted to humans by the same tick that transmits the agents of Lyme
disease and human granulocytic anaplasmosis. The incidence of babesiosis due to tick bites is increasing, and
it is also the most commonly reported blood transfusion-associated pathogen. Swift clinical diagnosis is
paramount because patients can rapidly progress to severe infection potentially leading to acute respiratory
failure, congestive heart failure, and renal failure. Rapid diagnostic tests for babesiosis do not exist. This is
problematic because patients often present with flu-like symptoms, and physicians must make their initial
diagnosis based on indirect clinical evidence and the patient's epidemiological risk factors. Confirmation by
reference laboratory testing typically takes several days, leaving a critical window of diagnostic uncertainty. This
Phase I project expands the aims of our work to develop an antigen capture ELISA that detects BmGPI12
(BmSA1), a secreted protein expressed in large amounts by the babesia parasite during active infection and
released in the blood of the infected host. The goal of this project is a rapid diagnostic test (RDT) in a lateral flow
assay (LFA) format that is rapid, highly sensitive and suitable for use by (i) physicians at the point of patient care
for the rapid patient diagnosis, and (ii) blood collection agencies at the time of a donor blood draws to prevent
Babesia entry into the donor blood supply.

Public health relevance
NARRATIVE Babesiosis is an emerging health threat that the CDC designated a nationally notifiable disease in 2011. It is also the most commonly reported blood transfusion-associated pathogen. Rapid diagnostic tests for babesiosis do not exist, and the consequence of untimely diagnosis of patient, or the entry of the babesia pathogen into the donor blood supply, can be life-threatening.